Understanding Metalloenzymes Mechanisms and Dynamics

PROJECT SUMMARY
Metal-containing enzymes or metalloenzymes represent more than 40% of all enzymes and
perform a wide variety of chemical transformations in cells with great biomedical importance.
The unique functionalities of the metalloenzymes result from the amazing synergy between the
properties of the metal center, the coordinated biological ligands, and last but not least, the unique
effects of the second coordination sphere (SCS) and long-range (LR) interactions with the protein
and its dynamics. Among the diverse classes of metalloenzymes, the Zn(II)-containing matrix
metalloproteinases (MMPs) and Fe(II)/2-oxoglutarate (2OG)-dependent oxygenases are in
special interest due to their intriguing structure-function relationships and biomedical
importance. Although both sets of metalloenzymes have been intensively studied and important
aspects of their structure-function relationships have been elucidated, there are a lot of missing
points that demand comprehensive investigation in the directions of revealing their catalytic
mechanisms, understanding the effects of the SCS and LR-interacting residues and elucidating
the correlation between the dynamics and catalysis. Providing the missing knowledge on the two
groups of metalloenzymes applying computational chemistry methods in correlation to
experiments is the long-term focus of the proposed research. The outcomes will contribute to
understanding the mechanisms of metalloenzymes, will provide missing elements to the enzyme
redesign protocols, and will help for the design of effective and specific enzyme inhibitors.

Public health relevance
Applying computational chemistry methods in correlation to experiments we will explore the structure-function relationships of Zn(II)-dependent enzymes and Fe(II)/2-oxoglutarate- dependent enzymes in importance for biomedicine, and drug design.